Bioinformatics for post-traumatic stress

Project Summary/Abstract
Maladaptive complications following trauma, including post-traumatic stress (PTS), are highly prevalent in both
veterans and civilians, and have been difficult to accurately diagnose, manage and treat. Debate regarding
diagnostic criteria and the need to represent the full spectrum of inter-connected features contributing to
psychopathology has spawned the development of the Research Domain Criteria (RDoC) by the National
Institute of Mental Health (NIMH). RDoC is a developing framework to help guide the discovery and validation
of new dimensions of mental health disorders and their relationships to underlying biological mechanisms.
NIMH now has a rich federated database that currently houses raw data from RDoC-sponsored clinical
research, and clinical trial data from the National Database of Clinical Trials (NDCT) with information that may
help to unlock the complex and overlapping relationships between symptoms of PTS and the underlying
biomarkers to fuel improvements on diagnostic and therapeutic frameworks for trauma recovery. The
proposed project will apply bioinformatics and machine learning analytical tools to these large, heterogeneous
datasets to identify and validate new research dimensions of trauma-related psychopathology and treatment
response trajectories and their predictors. Aim 1 will develop an in silico trauma patient population by
integrating data from diverse sources, including cross-sectional and observational longitudinal clinical studies
housed within available data repositories for trauma and other related mental health research. Data will include
medical history, demographics, diagnostic tests, clinical outcomes, psychological assessments, genomics,
imaging, and other relevant study and meta-data. Aim 2 will identify multiple dimensions of PTS diagnostic
criteria, using a combination of unsupervised dimension-reduction statistical methods, internal and external
cross-validation, and supervised hypothesis testing of predictive models to understand the heterogeneous
subtypes of PTS. Aim 3 will deploy unsupervised machine learning methods, such as topological data analysis
and hierarchical clustering, to identify unique clusters of patients based on symptomatology to develop
clustering methods for precision mapping of PTS patients based on disease severity. Aim 4 will use supervised
machine learning techniques for targeted predictive analytics focused on identifying treatment responders from
the NDCT, and identification of latent variables that predict treatment response. The results of the proposed
research project will greatly enrich the field of computational psychiatry research to identify conserved
dimensions associated with the complex relationships of psychopathology and precision treatment planning
following exposure to traumatic events.

Public health relevance
Project Narrative A recent restructuring of diagnostic and research criteria for psychiatric disorders has been implemented to promote greater understanding of the biological mechanisms involved in the development of complex mental health disorders. The proposed project aims to apply bioinformatics and machine learning analytics to large datasets from trauma-exposed patients to identify and validate dimensions of post-traumatic stress (PTS), relevant biological predictors, and precision treatment response trajectories.